International Brotherhood of Teamsters Hazmat Disaster Preparedness Training Program

Principal Investigator/Program Director (Last, First, Middle): Byrd, Lamont FOA Number RFA-ES-19-003
Program Summary/Abstract (HDPTP)
Project Title: International Brotherhood of Teamsters Hazmat Disaster
Preparedness Training Program
Application Organization Name: International Brotherhood of Teamsters
Address: 25 Louisiana Avenue, NW Washington, DC 20001
Project Director Name: Lamont Byrd
Contact Phone Number: 202-624-6960
Email Address: [email]
Website: teamsterworkertrainingprogram.org
Grant Program Funds Requested: $1,360,810
The International Brotherhood of Teamsters (IBT) Consortium is applying for funding to
conduct comprehensive health and safety training under the HDPTP to build institutional
competency, increase community resilience, and create a sustainable worker health and safety
training program. Workers and community members engaged in disaster response/recover
activities encounter myriad occupational hazards such as: working at heights, in excavations,
heavy lifting, falling objects, electrical hazards, and exposures to chemicals. Consequently, it is
critically important for these workers and community members to receive training to ensure that
they are able to identify occupational hazards and able to take actions to protect themselves, their
coworkers and the surrounding environment.
The IBT Consortium proposes to recruit workers within the targeted population through
relationships and partnerships with employers, unions, community-based organizations, and 10
regional training centers to conduct 295 classes for 4,455 workers during the 5-year funding
period. The IBT Consortium is in a unique position to deliver relevant, high quality health and
safety training to workers due to our infrastructure, mobile training capability, staffing,
extensive experience, and expertise.
The long term objectives and specific aims of the IBT Consortium are to increase worker,
community, and environmental safety and resilience by training workers to safely respond to
natural disasters.
IBT Consortium Page 1 Program Summary-Abstract (HDPTP)